Acylcarnitine Metabolism in Ovarian Cancer Chemoresistance

PROJECT SUMMARY ABSTRACT
High-grade serous ovarian carcinoma (HGSOC) is the most prevalent histosubtype of epithelial ovarian cancer.
Therapy for HGSOC relies on DNA damaging agents, with a high percentage of cancers having de novo or
acquired chemoresistance due in part to homologous recombination (HR) proficiency. Our preliminary data has
uncovered a potential metabolic mechanism contributing to HR proficiency that could be used for novel targeted
therapies for HGSOC. This proposal tests the overarching hypothesis that acetylcarnitine increases site specific
histone acetylation post-translational modifications that promote HR-mediated DNA damage repair and allow
resistance to standard-of-care DNA damaging agents in HGSOC. Manipulation of acetylcarnitine will therefore
sensitize HGSOCs to DNA damaging agents. This project will: 1) quantitatively and mechanistically map the
acetylcarnitine-dependent histone acetylation axis and its contribution to HR-mediated DNA repair; and 2)
interrogate whether interventions that suppress intracellular acetylcarnitine sensitize HGSOCs to standard-of-
care DNA damaging agents. Targeting acetylcarnitine metabolism for sensitization to DNA damaging agents is
a novel strategy. Ultimately, this research will help develop metabolic therapeutic strategies against
chemoresistance that occurs in many cancer patients.

Public health relevance
PROJECT NARRATIVE Epithelial ovarian cancer is the most lethal gynecological malignancy where resistance against current therapies occurs in a high percentage of disease. This project will test a major required metabolic component of this chemoresistance and elucidate targetable steps in chemoresistance.